Child Maltreatment and Honesty

[unreadable] DESCRIPTION (provided by applicant): A team of researchers with expertise in developmental psychology, child and family law, and forensic psychology propose a series of studies to examine honesty in young maltreated and non-maltreated children. The proposal consists four interconnected projects. The first project will examine the development of children's understanding of concepts underlying honesty, including early conceptions of the distinction between the truth and lies, the evaluation of secret-keeping regarding transgressions, and the evaluation of the obligations underlying promises. The second project will examine the determinants of honesty, varying the actions of instigators who may encourage dishonesty and recipient-interviewers who encourage honesty, and assessing characteristics of the child that may have an influence, including maltreatment status, age, and attitudes about honesty. The third project will examine the verbal and nonverbal indices of honesty in children who were coached to lie by instigators or encouraged to be truthful by recipients. The fourth project will examine whether either lay or professional adults are able to distinguish honest from dishonest children. The research will test hypotheses that maltreated children's understanding is subject to underestimation due to insensitive tasks, that maltreated children's honesty can be increased through various means of truth induction, and that maltreated children's honesty can be discriminated through multidimensional analysis of verbal and nonverbal measures. The research is unique in its potential application to the investigation and adjudication of child maltreatment claims, insofar as it is the first sustained research program to utilize tools for assessing and influencing honesty that are potentially useful to child maltreatment professionals and to examine the utility of those tools in children who are in fact the subject of intervention. The findings have potential to improve child maltreatment practice and thus to ensure that children who do in fact need protection from maltreatment are detected and their reports believed. [unreadable] [unreadable]